Controlled expression of a cystatin C-peptide as therapy for Alzheimer's disease

DESCRIPTION (provided by applicant): Alzheimer's disease (AD), a fatal neurodegenerative disorder, afflicts close to 26.6 million people worldwide. It is characterized by accumulation in the brain of insoluble, extracellular amyloid plaques and intracellular neurofibrillary tangles considered to be, until recently, the main cause of brain dysfunction. This view has been recently reformulated to focus on soluble oligomeric Ab (oAβ) aggregates, with emphasis on the role of Aβ42 oligomers, which are believed to cause synaptic dysfunction and eventual neuronal loss in the vulnerable regions of AD brains. Cathepsin B, a cysteine protease present in the brain, can degrade Aβ peptides, however, blocking its enzymatic activity in vivo with its specific inhibitor, cystatin C (CysC), rather than increasing, lowered Aβ peptide brain deposition in AD models. Because a portion of the CysC protein (aa101- 117), distinct from its enzyme inhibitory sequence, can bind to Aβ and inhibit fibril formation in vitro, we propose that generating sufficiently high levels of this peptide in vivo, might reduce Aβ oligomerization and neurotoxicity. We showed a) that synthetic CysC-Aβ-Binding Peptide (CysC-AβBP) binds specifically and preferentially to purified Aβ42, b) that in b AD mouse models, one with amyloid plaques and oAβ (TgCRND8) and one with oAβ only (APPE693Q), it co-localizes with the Aβ deposits in neocortex and hippocampus when incubated with brain sections in vitro, c) that similar co-localization is found 4 days after a single intranasal delivery of the peptide and d) that intranasal delivery of a CysS-GFP-expressing construct under a promoter that we have shown to be highly upregulated in the brain by several hormones produces detectable expression levels. We propose: 1. To identify conditions that generate optimal levels of CysC-AβBP in the brain. This will be done by comparing intranasal to intrathecal delivery of purified peptide and peptide-expressing construct, uncoated or encapsulated in microparticles, and to test which positive hormonal regulators of the CysS promoter optimally transactivate the CysC-AβBP construct. 2. To test whether high levels of CysC-AβBP will reduce Aβ-oligomer deposits in established AD and whether chronic treatment of mice before AD onset will prevent its development. Experimental conditions deemed most effective in Aβ oligomer reduction in response to CysC-AβBP will be utilized to test the effect this treatment has on improvement of learning and memory. By proposing to use an AβBP-fibril blocking CysC peptide, rather than the complete CysC protein, with its detrimental enzyme inhibitory activity, and by finding novel ways to deliver regulate and maximize CysC-AβBP expression in the brain, we expect to achieve beneficial effects that might be translated into therapeutic and preventive approaches to AD in humans.

Public health relevance
Close to 27 million people live with Alzheimer's disease worldwide and the number is rapidly rising. This disease robs its victims of dignity and places untold burden on families and on the economy. We propose to test in a mouse model of Alzheimer's disease a relatively simple novel method of preventing and/or averting the neuronal degeneration and of rescuing function.